Mouse Breeding and Procedure Core

Summary
The Mouse Breeding and Procedure Core (Core C) is essential for the smooth functioning of the Program
Project. Core C has two major functions. First, Core C will provide and oversee mouse breeding and genotyping
services. Mice will be bred centrally for all three projects of the Program Project in order to maximize quality
control and consistency of mouse lines, and to maximize efficiency, particularly for lines shared across the three
Projects. Mice will be mated, born, separated, and weaned by the Core members. The Core will direct tails for
genotyping to NYU Core for Genotyping Services. Once genotyped, Core C will allocate mice to either further
breeding or to experimentation depending on the needs and the genotype/sexes of mice obtained. Core C will
distribute all mice for studies to the three Projects by age 6 weeks. As indicated in the individual Projects, Core
C, through Core A, implements randomization and strategies that will be essential for rigor and reproducibility
and protection against bias. Second, Core C will coordinate and perform mouse procedures. Shared procedures
across the Program Project to be performed and overseen by Core C include: aorta transplantation surgery,
lethal irradiation and bone marrow transplantation; adipose tissue transplantation; parabiosis; glucose and insulin
tolerance tests; imaging studies (liver ultrasound and magnetic resonance imaging and DEXA scanning);
isolation of primary cells from the liver, including hepatocytes, Kupffer cells and hepatic stellate cells and isolation
of extracellular vesicles. Core C will serve all three projects of the Program Project over all five years.